RESPONSE TO POSTURAL CHANGE IN CRAMPING AND NON-CRAMPING DIALYSIS PATIENTS

The purpose of this protocol is to compare the response of hemodialysis patients with frequent dialysis-associated cramps with that of patients who cramp only infrequently in order to better understand the pathophysiologic basis of these cramps. The study was completed in the past year.